HWW

Program Summary/Abstract (HWWTP)
The Steelworkers Charitable and Educational Organization (SCEO), the non-profit (501c3) arm of the United
Steelworkers (USW), is applying for HWWTP and HDPTP funds to support a vibrant training partnership
linking two of the largest U.S.-based industrial unions with rapidly expanding immigrant worker centers and
Tribal communities. The SCEO’s training entity, the Tony Mazzocchi Center (TMC), brings together the
USW, the Communications Workers of America (CWA), the Labor Institute (LI), the National Day Labor
Organizing Network (NDLON), Make the Road New York (MRNY) and the Umatilla, Cayuse, Walla Walla,
Yakama, and Nez Perce Tribes.
Through the HWWTP five-year program, we will conduct 2,265 courses to reach 50,075 workers,
managers, community residents and Tribal members with 545,200 hours of training to help
prevent toxic releases, fires, explosions, injuries, sickness and death. A primary focus is on training and
mentoring union, immigrant and Tribal H&S advocates to promote concrete and lasting prevention at their
worksites and on their Tribal lands.
Target Populations: The TMC has access to over 6,000 workplaces and worker centers including the USW
(600,000 members), the CWA (600,000 members), NDLON (55 worker centers) and MRNY (23,000
members at 5 centers). TMC Tribal partners include Umatilla, Cayuse, and Walla Walla (3,000 members); the
Yakama (31,000); and the Nez Perce (18,800). Our training populations are employed in metal mining,
refining, milling and manufacturing; telecommunications; transportation; oil refining, pulp and paper mills
and manufacturing; chemical manufacturing and synthesis; nuclear energy; rubber and plastics;
pharmaceuticals; automobile parts; electrical, appliance and other manufacturing; cement; construction;
shipbuilding; health care, and education. Immigrant day-laborers and temporary workers are employed in
clean-up activities, especially during emergencies; construction; cleaning; home care; warehousing; and
distribution. Tribal workers engage in emergency services including fire, police, and medical services as well as
in the construction trades. Approximately 850,000 of these workers are potentially exposed to hazardous
substances covered by OSHA Standard 29 CFR 1910, EPA 40 CFR 311, and DOT 49 CFR 171-177.